Utilizing continuous ketone monitors to enable safe use of SGLT inhibitors in patients with Type 1 Diabetes

PROJECT SUMMARY/ABSTRACT
Sodium-glucose cotransporter inhibitors (SGLTis) improve glycemia in type 1 diabetes (T1D) and provide
important cardiorenal benefits. However, their use in T1D is restricted due to an increased risk of diabetic
ketoacidosis (DKA). As a result, patients with T1D are left unable to realize the numerous benefits that this
class of medication offers. Fortunately, continuous ketone monitors (CKMs) have been developed to provide
real-time ketone data to patients and, for the first time, the potential for safe use of SGLTis.
Through extensive research in patients with T1D using SGLTi, three critical gaps have been identified that
require attention. First, individuals using insulin pumps face the highest risk of DKA, which is particularly
concerning as the majority of patients in the US currently use pump therapy. Therefore, it is crucial to
understand the differences in DKA risk between insulin pumps and multiple daily insulin injections, and to find
ways to reduce this added risk. Second, while higher doses of SGLTi therapy offer additional clinical benefits
such as improved glucose control and weight reduction, they also pose a higher risk of DKA. Thus, evaluating
whether CKM devices can enable the safe use of all clinically viable doses is necessary. Third, healthcare
practitioners need clinical predictors of ketosis risk to aid in selecting appropriate patients for SGLTi therapy.
This proposal aims to address all three of these identified gaps.
To achieve the study objectives, a two-arm, cross-over clinical trial is proposed involving participants using
MDI (n=26) and Hybrid Closed Loop insulin pumps (HCL; n=26). Participants will receive the SGLTi
sotagliflozin at both 200 mg and 400 mg in random order for 6 weeks, with CKM used during a 2-week
baseline and throughout the study. HCL participants will undergo an additional 6-week treatment period during
which a daily basal injection will supplement their HCL therapy. Half of their basal requirement will be provided
by the injection and half will be provided by the pump. This approach aims to safeguard pump users from
developing ketosis in case insulin delivery from their pump is interrupted. At baseline and after 2 weeks of
each treatment, a comprehensive clinical profile—including patient demographics, lab analysis, and CKM
data—will be completed to identify predictors of ketosis. The rationale for this work is that CKM can be
leveraged to define and mitigate ketosis risk in individuals with T1D receiving SGLTi therapy.
The specific aims are designed to assess risk of different modes of insulin administration (Aim 1a), if pump
risk can be mitigated with the addition of basal insulin (Aim 1b), risk associated with dose of SGLTi (Aim 2)
and using clinical data to identify key predictors of ketosis risk (Aim 3).
Impact: This work will have a rapidly translatable impact on enabling T1D patients to benefit from this vital
medication class.

Public health relevance
PROJECT NARRATIVE The proposed research aims to meet a critical public health need by offering a practical approach for individuals with type 1 diabetes to utilize and derive benefits from sodium-glucose cotransporter (SGLT) inhibitor medications. Leveraging novel continuous ketone monitoring technology can effectively lower the risk of diabetic ketoacidosis and enable the safe adoption of SGLT inhibitors in this population. The project aligns with the NIDDK mission to advance diabetes research to improve people’s health and quality of life.